EVALUATION OF TECHNIQUES FOR THE ANALYSIS OF LIPOPROTEINS AND APOLIPOPROTEINS

Because of the high prevalence of dyslipoproteinemias and their association with atherosclerotic cardiovascular disease (CVD), measurements of plasm lipids, lipoproteins, and apolipoproteins are often required for diagnosis and follow-up of patients. We establish techniques for the phenotyping and quantitative measurement of Lp (a) and for the measurement of apolipoproteins A-1 and B.